Quality control and spatial regulation of bacterial condensates

PROJECT SUMMARY/ABSTRACTS
Condensates play a crucial role in spatially organizing and regulating biochemical reactions. Dynamic
condensates arise from phase separation, while insoluble aggregates result from protein misfolding. Although
both can manifest as fluorescent foci in bacterial cells, they exhibit distinct biophysical properties and cellular
functions. Overcoming the challenge of probing the material state of these nanometer-sized foci in small
bacterial cells, I developed an experimental framework to assess phase separation in bacteria during my
postdoctoral training. My framework also challenges the paradigm that inclusion bodies are solid aggregates,
and calls for a thorough re-examination of processes primarily studied with inclusion bodies, such as protein
quality control (PQC). In the same study, I demonstrated that the material state of protein complexes indeed
influences their association with chaperones. While bacterial inclusion bodies are nucleoid-excluded and
localize at the cell poles, functional condensates can be dynamically positioned on the nucleoid, as observed
with carboxysomes. Carboxysomes are bacterial microcompartments responsible for CO2 fixation. The
carboxysome positioning system represents the only known system for condensate positioning and the
governing mechanism is still unclear. Therefore, this proposal for a K99/R00 Pathway to Independence seeks
to determine how the material state of protein complexes influences mechanisms of PQC (Aim 1), and to
develop minimal positioning systems for studying and manipulating condensates in bacteria (Aim 2). The
outcomes of this work will advance our understanding of the differences in PQC principles governing bacterial
condensates and aggregates, and contribute to determining the mechanism(s) of spatial regulation of bacterial
condensates. These contributions are expected to lay a robust foundation for the development of therapeutics
targeted at condensates and tools to spatially organize them. Building on the systems and methods developed
in this proposal, my long-term goal is to establish an independent research group investigating (i) how the
material state of protein complexes influences cellular processes that condensates are involved in, such as cell
division and pathogenesis, and (ii) investigating the formation, functions, and spatial regulations of
condensates and bacterial microcompartments from uncultivable bacteria in the human microbiome. The
proposed training will provide me with the additional scientific expertise, including technical training in cell-free
reconstitution and live-cell single-molecule tracking. This award will further my professional development
including formal training in laboratory management, grant writing, and a tailored plan to support my
applications to faculty positions. The University of Michigan, with its exemplary scientific and professional
environment, is an ideal setting to support the training outlined in this proposal and ensure my success in
launching an independent research program.

Public health relevance
PROJECT NARRATIVE Dynamic condensates are generally beneficial, whereas most insoluble aggregates are toxic. Understanding the distinct regulations of aggregates and condensates is essential for designing fundamentally different therapeutics to control and target diseases associated with these structures. The proposed work aims to elucidate mechanisms of bacterial condensate quality control and develop minimal positioning systems to study and manipulate bacterial condensates, providing potential tools for the study of infectious diseases and the development of therapeutics to improve human health.